PATIENT-TAILORED PHYSICAL ACTIVITY INTERVENTION AMONG OLDER WOMEN WITH GYNECOLOGIC CANCERS UNDERGOING CHEMOTHERAPY (FIT4TREATMENT)

PROJECT SUMMARY
Older patients with gynecologic cancers have increased advanced stage at presentation, more aggressive
histology and more commonly require adjuvant chemotherapy. This chemotherapy, as well as underlying cancer,
cause accelerated aging and toxicity, leaving women vulnerable to functional decline, increased frailty,
decreased health related quality of life. Physical activity has been shown to improve functional health, improve
quality of life, slow aging, and decrease rates of frailty and sarcopenia. However, limitations exist in allowing
older gynecologic cancer patients to access existing physical activity interventions, namely that many are
delivered in person and do not account for the varied time course of symptoms related to chemotherapy. The
use of remotely delivered mobile health (mHealth) technology-based physical activity interventions has been
shown to increase physical activity in diverse populations including patients with metastatic cancer and older
adults.
The objective of this study is to use a multi-phase optimization strategy (MOST) clinical trial design to determine
which components of an mHealth physical activity intervention (Fit4Treatment) delivered over 12 weeks with a
12 week follow-up meaningfully contribute to increasing physical activity of any intensity among older women
with gynecologic cancer receiving chemotherapy. Participants will be randomly assigned to a combination of
zero to four different intervention components using a full factorial design to estimate the effects of each
component on increasing steps. The Fit4Treatment components include 1) symptom burden tailored goal setting
2) social support through an exercise care partner 3) treating oncology provider engagement and 4) coaching.
We will also test how changes in physical activity improve patient-reported outcomes (physical function, fatigue,
anxiety, quality of life), aging outcomes (frailty, functional performance) and cancer outcomes (chemotherapy
delays, progression free survival). Finally, we will examine both mediators (adherence, self-efficacy) and
moderators (age, treatment dose, cancer type) of the effects of the components of the Fit4Treatment on
increasing physical activity.
This research expands upon the robust work of our group examining the use of well-tested, patient-led, physical
activity interventions to improve cancer patients’ health and survival, and is innovative in the use of an efficient
MOST study design, examining a new high-risk population, and testing the effects of physical activity on aging
and functional outcomes. This study will lead to an improved understanding of how to effectively increase
physical activity among older patients with gynecologic cancers, a high-need and understudied population.
Ultimately, these results will improve the health, quality of life and survival of older cancer survivors.

Public health relevance
RELEVANCE Older women with gynecologic cancer receiving chemotherapy experience treatment toxicity, increased frailty, and impaired quality of life. Physical activity may mitigate these effects. The findings of this study will result in a scalable and efficient physical activity intervention (Fit4Treatment) specifically designed for these survivors to ultimately improve their health, quality of life and survival.